Enhanced persistence of CAR Tregs in the CNS for Alzheimer’s disease therapy

Abstract
Alzheimer’s disease (AD) is a progressive neurodegenerative disease that is one of the primary reasons for
memory dysfunction and dementia after 60 years of age. Neuronal dysfunction and death in the frontal cortex
and hippocampus, along with microglia-mediated neuroinflammation and formation of aberrant protein
aggregates and fibrils are hallmarks of AD. Sporadic and familial forms of AD have an overproduction and/or
decreased clearance of extracellular amyloid-beta (Aβ) peptides and intraneuronal tangles of twisted tau protein
fibers. Neuroinflammation is known to occur in AD, and when associated near Aβ plaques there is a greater
neurodegeneration. Data suggest that inflammatory microglia, the resident macrophages of the central nervous
system, have a role in neurodegeneration and cognitive decline. Aberrant innate immune responses and altered
inflammation are associated with AD and are involved in AD disease in murine models. Data show that
inflammation modulators may be beneficial, but a challenge is how to delivery anti-inflammatory therapy that
provides multiple mechanisms rather to the site of disease. T regulatory cells (Tregs) are a subset of T cells that
have inherent anti-inflammatory activity. Tregs are found in the CNS under steady state conditions and increase
in regions of CNS inflammation. Although the overall role for Tregs in AD is not well understood, many studies
support a potential beneficial role for Tregs in AD. Our therapeutic strategy is to target Tregs to rebalance
cerebral immunity, promote Aβ clearance, and limit neuron damage. However, key challenges for Treg therapy
are that polyclonal Tregs do not target disease-associated antigens and there is no IL-2 in the CNS to support
Treg persistence. We hypothesize that chimeric antigen receptor (CAR) Tregs targeted to AD-associated
antigens that are engineered to persist will solve these key problems. We have chosen to use CARs that bind
aggregated amyloid-beta (A-β), so that the CAR Tregs will be triggered at the site of A-β plaques. CAR cell
therapy is a great approach for therapy because cells as drugs can traffic to sites of disease, persist in vivo
(when engineered to do so), respond to the environmental cues (e.g. antigen) to trigger or limit activities, and
delivery multiple therapeutic mechanisms.

Public health relevance
Project Narrative In this project, we will pursue a novel therapeutic strategy designed to enhance the persistence and activity of targeted T regulatory cells for the treatment of Alzheimer’s Disease. We will focus on understanding how these engineered T regulatory cells affect behavior, longer-term persistence, inflammatory activity, microglial cells, and improve efficacy with the addition of therapeutic payloads, and examine potential unwanted effects of treatment.